TRACER Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Administrative Core of this P20 Cancer Disparities SPORE planning grant titled Translational Research
Center in Lung Cancer Disparities (TRACER) provides an essential framework for supporting the distinct features
as well as the more routine administrative tasks associated with a large, multi-institution, multi-project, and multi-
core planning grant. The Administrative Core will be led by a team of Multi-Principal Investigators (MPIs), along
with the guidance of an Executive Steering Committee, a Multi-Institutional Internal Advisory Board, an External
Advisory Board, and a Community Advisory Board. The MPI team includes Robert A. Winn, MD (Virginia
Commonwealth University Massey Cancer Center; Contact MPI), Chanita A. Hughes-Halbert, PhD (Medical
University of South Carolina Hollings Cancer Center), and Victoria L. Seewaldt, MD (City of Hope Comprehensive
Cancer Center). The Administrative Core has the following specific aims: 1) Provide overall logistical support
and facilitate coordination and communication for a multi-regional TRACER P20; 2) Monitor fiscal oversight for
TRACER; and 3) Develop, implement, and evaluate strategic plans and progress for the submission of a full P50
SPORE in lung cancer disparities.

Public health relevance
ADMINISTRATIVE CORE: PROJECT NARRATIVE The Administrative Core of the Translational Research Center in Lung Cancer Disparities (TRACER) will provide administrative oversight including fiscal management, integration and coordination with other cores, and evaluation. The Admin Core will also ensure proper internal and external communication.